NORMAL AND ABNORMAL SPEECH PRODUCTION

This project is concerned with normal and abnormal speech production, mainly from biomechanical and neuromotor perspectives. The three studies elaborated are concerned with respiratory function and are a continuation of thematic research that has been conducted in our laboratory over more than two decades. For the studies proposed, non-invasive methods will be used. Study #1A will longitudinally and cross-sectionally investigate and document the nature of the refinement of speech breathing in young children and provide a data base against which young children with speech breathing disorders can be compared. Study #lB will longitudinally investigate and document the nature of the emergence of speech breathing in infants-children with neuromotor problems associated with cerebral palsy. It will make a direct contribution to our understanding of the salient features of the control problems involved and suggest implications for the evaluation and management of children with neuromotor impairments. Study #1C will investigate the interaction between speech breathing and ventilation in normal adults and provide a data base against which adults with various disorders can be compared. This study will elucidate the mechanisms involved in drive-to-speak versus drive-to-breathe factors and will shed light on how cognitive, chemical, and mechanical factors converge at the speech breathing-ventilation interface.